The Pathophysiology of Type 1 Versus Type 2 Mutant Calreticulin-Drivenmyeloproliferative Neoplasms

Project Summary
Myeloproliferative neoplasms (MPNs) include primary myelofibrosis (PMF; characterized by the over-
proliferation of megakaryocytes and granulocytes with abnormal collagen deposition in the bone marrow stroma),
essential thrombocythemia (ET; increased megakaryocyte and platelet production), and polycythemia vera (PV;
increased red cell production, hemoglobin, and hematocrit). Although all MPN driver mutations lead to
constitutive activation of JAK/STAT signaling, targeted JAK inhibitors are not curative and fail to alter disease
progression. Therefore, there is a great unmet need to identify novel curative therapies for MPNs. Mutations in
calreticulin (CALR) represent the second most common genetic abnormality in MPN. The CALR gene encodes
a calcium (Ca2+)-binding chaperone protein that primarily resides in the endoplasmic reticulum (ER). All CALR
mutations share an identical neomorphic C-terminal peptide, which permits binding to the thrombopoietin
receptor MPL and the subsequent activation of pathogenic JAK/STAT signaling. The majority of CALR mutations
are classified as either type 1 or type 2 based on the extent of homology to the wild type protein, where type 1
proteins exhibit complete loss of C-terminal Ca2+ binding sites that are retained in type 2. Despite their shared
mutant C-terminus and ability to bind and activate MPL, type 1 and 2 CALR mutations engender significant
phenotypic and prognostic differences. Type 1 mutations are more common in PMF, and are associated with
increased risk of myelofibrotic transformation from ET. Conversely, type 2 mutations are primarily associated
with ET, exhibit low incidence of myelofibrotic transformation, and are rarely found in PMF. The mechanisms
underlying these divergent clinical phenotypes remain unknown. We discovered that the IRE1a/XBP1 pathway
of the unfolded protein response (UPR) is differentially activated in type 1 versus type 2 mutant CALR cells, and
that type 1 mutant CALR cells are dependent on this pathway for survival and to drive ET. We found that
IRE1a/XBP1 is activated only by type 1 and not type 2 mutant CALR due to a loss of calcium binding function
specific to the type 1 protein. More recently, we found that the ATF6 pathway of the UPR is differentially up-
regulated in type 2 compared to type 1 mutant CALR cells, and that type 2 mutant proteins exhibit loss of
molecular chaperone function. These data support the central hypothesis that type 1 and type 2 CALR
mutations activate and depend on different arms of the UPR based on their respective losses of function, and
that these pathways promote distinct disease phenotypes. Thus, targeting different arms of the UPR based on
mutation type may represent a novel, individualized treatment strategy for type 1 versus type 2 CALR+ MPN
patients. To test this hypothesis, we will dissect the role of the UPR in type 1 mutant CALR-driven fibrosis
(Specific Aim 1) and type 2 mutant CALR-driven ET (Specific Aim 2), and determine if each is uniquely
sensitive to therapeutic targeting of different arms of the UPR (Specific Aim 3).

Public health relevance
Project Narrative Approximately 40% of myeloproliferative neoplasms (MPNs) are driven by mutations in the gene calreticulin (CALR), which are classified as either type 1 or type 2. Both type 1 and type 2 CALR mutations have identical mutant C-termini, but for reasons that remain unknown, they engender distinct disease phenotypes with significant prognostic differences. Based on our recent finding that type 1 and 2 CALR mutations activate different arms of an ancient cellular stress response pathway called the unfolded protein response (UPR), we propose to test the hypothesis that differential UPR activation leads to the divergent clinical phenotypes seen in type 1 versus type 2 CALR patients, and that these pathways can be uniquely targeted for therapeutic gain in type 1 versus type 2 CALR-driven MPNs.